ENDS aerosol particle deposition, in utero exposures and children's respiratory health effects (ENDURE)

Summary
This project leverages the unique resources of three different institutions to assess offspring
respiratory health impacts caused by in utero exposures to Electronic Nicotine Delivery Systems
(ENDS) products. ENDS are a diverse class of products such as electronic cigarettes (e-cigs),
vaporizers, vape pens, and pods. In this study, we focus on e-cigs as they are the most adopted
ENDS devices in recent years. Over 9 million American adults, including women of childbearing
age, are current e-cig users. Little, however, is known about the effects of fetal exposures to e-
cig aerosols on lung development in the offspring. We propose the “ENDS aerosol particle
deposition, in utero exposures and children’s respiratory health effects (ENDURE)” consortium to
investigate ENDS aerosol particle deposition in the lungs of mothers who used ENDS products
(vaping) or were exposed to household ENDS aerosols and examine the resulting effects on the
offspring’s respiratory health. The ViCTER mechanism provides an exceptional opportunity to
enhance cross-disciplinary and translational research to study in utero exposure to tobacco
products from maternal or environmental sources and its effects on the trajectory of lung health.
We hypothesize that constituents of ENDS aerosols with the highest maternal lung deposition will
result in the dysregulation of lung inflammatory genes in the offspring, particularly IL-10, leading
to asthma susceptibility. To test our hypothesis, we will investigate the deposited dose of harmful
substances from ENDS aerosols in human airways and estimate associated health risks (Aim 1).
This aim will provide critical information on the deposited dose of ENDS-related harmful
substances in the alveolar region through active and passive vaping and associated health risks.
Informed by preliminary studies, we will use ENDS products whose aerosols significantly deposit
in the lower airways (Vuse and NJOY) and assess the role of Il-10 gene regulation on pulmonary
function, inflammation, and lung epigenome in utero ENDS-exposed mouse offspring (Aim 2). For
this aim, we will use wild-type (WT) and Il-10 knockout (KO) mouse models with and without
house-dust mite (HDM) treatment, to investigate the role of Il-10 in adversely altering airway
resistance, inflammation, and the lung epigenome of in utero ENDS exposed offspring in early
life. Finally, we will determine the impact of parental ENDS use on infant recurrent wheeze and
asthma-like symptoms, and buccal DNA methylation in a cohort of children from Indiana (Aim 3).
This project will help bridge the knowledge gap of which ENDS aerosols enter the fetal-maternal
circulation and trigger dysregulation of genes associated with the offspring’s lung function and
lung development.

Public health relevance
Narrative The use of Electronic Nicotine Delivery Systems (ENDS) during pregnancy is a significant and emerging public health problem, as ENDS aerosol exposures during the prenatal period has the potential to influence children’s respiratory health. To better understand in utero ENDS aerosol exposures and their relationship to pulmonary inflammation in the offspring, we combine a 3-D lung model, murine models, and population level data. Data from this project will provide critical information to inform recommendations about ENDS use, and the mechanisms by which ENDS exposure in the prenatal period affect the trajectory of lung health.